Elucidating mediators of genetic instability in Candida glabrata

Candida glabrata is an opportunistic fungal pathogen associated with high mortality and whose incidence is
increasing due to its high frequency of resistance to the widely used azole antifungal class. C. glabrata also
rapidly evolves resistance to echinocandins and can become multi-drug resistant and thus virtually impossible
to treat. Drug resistance in C. glabrata is acquired via specific genetic variants. C. glabrata is also notable for its
remarkable genetic diversity, manifested by a variety of karyotypes and high levels of short nucleotide
polymorphisms (SNPs) among strains. However, how C. glabrata facilitates genetic instability is almost entirely
unknown. A major source of genetic instability in all examined biological systems are DNA double-strand breaks
(DSBs), which mediate chromosome rearrangements and are associated with high rates of point mutations in
nearby regions. Thus, both chromosome rearrangements and SNP variation across C. glabrata strains are
consistent with DNA DSBs being the major source of this genetic diversity. Indeed, our preliminary studies
showed that C. glabrata experiences DNA breaks and develops chromosome rearrangements and drug-resistant
mutations during its interaction with host cells, e.g., while residing in macrophages, and that deletion of DSB
repair gene RAD51 in C. glabrata significantly increases the emergence of drug-resistant mutants in the mouse
gastrointestinal colonization model. This proposal is based on the hypothesis that C. glabrata has evolved
mechanisms that facilitate genetic instability upon DNA damage and that to understand these mechanisms it is
necessary to understand how C. glabrata generates and processes DNA DSBs. In Specific Aim 1, we propose
to use DSB chromatin immunoprecipitation followed by next generation sequencing (DSB-ChIP-seq) and END-
seq (a highly sensitive, unbiased next-generation sequencing technique for quantitatively mapping DSBs at
nucleotide resolution across the genome) to identify “fragile” loci prone to DSB formation in C. glabrata, based
on the hypothesis that these loci are the most likely mediators of genetic instability. In Specific Aim 2, we will use
DSB-ChIP followed by mass spectrometry (DSB-ChIP-MS) to identify C. glabrata proteins that mediate DSB
transactions. In both Aims, the roles of selected identified loci/genes in DSB formation/processing and genome
stability will be validated experimentally. The proposed study will fill a large gap in knowledge and provide
information essential for understanding how C. glabrata promotes genetic diversity and evolves drug-resistant
variants. Karyotype instability and aberrant DSB repair are also hallmarks of many cancers, and in that context
understanding the mechanisms underlying DSB formation and processing has been instrumental in developing
effective therapeutic approaches targeting DSB repair mechanisms, e.g., by using PARP inhibitors. Thus, this
proposal will provide the first understanding of DSB formation and processing in C. glabrata and may identify its
“Achilles’ heel”, i.e., a mechanism that allows it to generate genetic diversity but also makes it more sensitive to
agents that disrupt or compromise DSB repair.

Public health relevance
Candida glabrata is an opportunistic fungal pathogen whose incidence is increasing due to its high intrinsic resistance to azole antifungals, and it also rapidly evolves resistance to echinocandins, leading to multi-drug resistant strains that are virtually impossible to treat. C. glabrata is also notable for its remarkable genetic diversity, which is hypothesized to be driven by the same mechanisms as its ability to rapidly evolve drug resistance. The proposed study will elucidate these mechanisms in C. glabrata by identifying factors that mediate the formation and processing of mutagenic DNA double-strand breaks.